Single cell and spatial genomic analyses of specimens from patients with autoimmune diseases (Technology Core)

To better understand the molecular and cellular pathways driving autoimmune diseases, we propose to
deeply profile biological samples from patients with rheumatoid arthritis (RA), psoriasis (Ps), psoriatic arthritis
(PsA), primary Sjögren’s syndrome (pSS) and systemic lupus erythematosus (SLE). Working closely with the
AMP AIM network, we will focus on the cohorts and clinical questions defined by the network of clinicians,
biologists and computational biologists together with industry and non-profit partners. For our Technology
Core, we selected leading-edge multi-dimensional technologies to deeply profile end organs as well as
peripheral blood from patients with autoimmunity. We assembled a team of investigators with expertise in each
disease and tissue type, and who have already demonstrated the ability to develop and implement high-
throughput pipelines to profile tissue and blood samples. To help us design and interpret the studies, we
recruited a team of collaborators and consultants with clinical expertise in each disease, with pathology
expertise in each tissue and with technical expertise in spatial profiling methods. In the first year, we will carry
out the pilot phase to optimize pipelines for: i) preserving and disaggregating tissues; ii) profiling single cells
using scRNA-seq/CITE-seq/TCR-BCR-seq; iii) profiling single nuclei by snRNA-seq/snATAC-seq; iv) preparing
tissues for two complementary, leading-edge methods for spatial transcriptomics (Visium) and transcript
imaging (MERFISH). We will iterate the protocols to optimize cell viability and yield, technical quality metrics
specific to each technology and the representation of all cell types. In year 2, we will run the full set of scaled-
up technology pipelines using ~50 samples per tissue type, and will assess data quality, site and batch effects
and technical artifacts to inform potential modifications for the single-cell pipeline. In Years 3-5, we will profile
the remaining ~1000 biopsies and ~1000 blood samples collected by the disease teams. We will develop a
computational pipeline for data pre-processing, primary biological analysis and quality metrics (including
technical and biological parameters at the scale of genes, cells and tissues) with customized features for each
tissue and disease. Our findings will be rapidly communicated within our Technology Core and across the
Network to the Disease Teams, Systems Biology Core, network committees overseeing the project, NIH, FNIH
and our industry and non-profit partners. We will also respond in real time to advancing changes in
technologies and work with the network to pilot and scale up critical methods. The result of the proposed
studies will be a set of multi-dimensional datasets that will be shared with the network and the larger
community, and provide a basis for cutting edge disease deconstruction and reconstruction across
autoimmune end organ pathologies and thus fulfill the vision of AMP-AIM.

Public health relevance
Systemic lupus erythematosus (lupus), rheumatoid arthritis, psoriasis, psoriatic arthritis and Sjogren’s syndrome are autoimmune diseases in which white blood cells produce inflammation in the kidneys (nephritis), joints (arthritis), skin (scaly patches) and glands (salivary in mouth and lacrimal in eyes (dry mouth and eyes), respectively. Current treatments for these diseases leave a large unmet need. By examining the cells of the involved tissues one cell at a time and learning which genes each cell expresses, we will identify new targets for drug development to treat these conditions.